Impact of Asymptomatic CMV on Cardiovascular Event Risk in Treated HIV

People with HIV (PWH) remain at higher risk for Type 1 myocardial infarction (T1MI), ischemic stroke, and
venous thromboembolism (VTE) than the general population despite antiretroviral therapy (ART)-mediated
viral suppression. These risks may be accentuated in women with HIV, particularly after the menopausal
transition. Systemic inflammation persists in many PWH despite ART and predicts each of these vascular
events, but the optimal interventional targets remain unclear. We and others have implicated cytomegalovirus
(CMV) co-infection as a potentially important therapeutic target to reduce inflammation-associated vascular
disease risk in treated HIV. In particular, our recent clinical trial of the CMV-specific antiviral drug letermovir
demonstrated that suppressing asymptomatic CMV reshapes the plasma inflammatory and cardiometabolic
proteome, decreasing several inflammatory and angiogenesis pathways that may play a role in both
cardiovascular and VTE risk, but whether these changes are causally associated with disease risk in treated
HIV infection remains unknown. It also remains unclear whether these CMV-associated pathways are
preferentially active in women with HIV. To address these issues, we are leveraging data from our clinical trial
of letermovir and are building upon our case-cohort study within the CFAR Network of Integrated Clinical
Systems (CNICS) of 1,994 ART-suppressed people with HIV, 485 of whom experienced subsequent vascular
events, and all of whom have GWAS data available. With these resources, we will perform by far the largest
Mendelian Randomization study to date of causal proteomic predictors of cardiovascular and VTE events in
treated HIV, including pathways linked to CMV replication and those that are modified by natal sex. Aim 1 will
assess whether CMV-associated plasma proteomic signatures as well as CMV-specific neutralizing antibody
titers (a novel measure of prior CMV burden) are associated with incident T1MI, ischemic stroke, and VTE in
treated HIV. Aim 2 will assess whether CMV-associated plasma proteins are causally associated with T1MI,
ischemic stroke, and VTE by Mandelian Randomization in this setting. Aim 3 will assess sex differences in
these CMV-associated plasma inflammatory and cardiometabolic proteins, whether sex modifies the
association between these markers and vascular events, and the degree to which the menopausal transition
may modify these pathways. These studies leverage a multidisciplinary team with expertise in translational
immunology, HIV and CMV pathogenesis, vascular disease, epidemiology, and bioinformatics and will create a
resource that can be leveraged by others to assess predictors of other disease outcomes and/or add additional
analytes. Collectively, these studies will help clarify the potential clinical implications of CMV-associated
biomarker changes, the mechanisms by which sex modifies the relationship between inflammation and
vascular diseases, and accelerate the identification of novel interventional targets to reduce multi-morbidity in
people with treated HIV.

Public health relevance
People with HIV, particularly women, remain at higher risk for vascular disease (e.g., heart attack, stroke, and blood clots in the veins) than the general population. Cytomegalovirus (CMV) is a common co-infection in people with HIV that has been linked to each of these risks, but we don’t yet understand the degree to which the biologic pathways induced by CMV are causally associated with these diseases. This study will determine whether the immunologic and cardiometabolic pathways driven by CMV in people with HIV are causally linked to the subsequent risk of heart attacks, strokes, and blood clots, and whether those pathways are preferentially active in women.